Broad-based spike protein stalk-based vaccine platform for SARS-CoV-2 and other coronaviruses

Project Summary/Abstract
We propose to develop a subunit vaccine for SARS-CoV-2, using a structure-based approach targeting
conserved and functionally essential domains in the stalk region of the viral spike protein. We expect our vaccine
platform to be applicable and effective across a wide range of existing and emerging coronaviruses. As our
system is based on expression in E. coli is it expected to be cost–effective, and our stalk-based approach is
specifically designed to cover a range of distinct coronaviruses. However, it is important to note that our vaccine
platform is highly flexible, with the antigen able to be re-engineered rapidly in the face of a novel coronavirus that
may emerge, and for which the vaccine developed in this application is not effective.

Public health relevance
Project Narrative We propose to develop a novel, cost-effective, and highly flexible vaccine platform to immunize against SARS- CoV-2. We will use an innovative subunit vaccine design approach, based on conserved epitopes in the coronavirus spike S2 fusion domain, express the vaccine platform in E. coli, and test both the serological and protective response in a mouse model. Due to the conserved nature of the structural region targeted, we anticipate that our stalk-based approach will be applicable to and effective across a wide range of existing and emerging coronaviruses.